Improving the HIV Care Continuum for Youth in the Deep South through Mobile Health Technology

PROJECT SUMMARY/ABSTRACT
Youth living with HIV (YLHIV) display elevated risk at every point of the Care Continuum. They face barriers
to becoming engaged and retained in HIV care, show poor medication adherence, and thus often fail to achieve
viral suppression. HIV-positive youth in the Deep South have particularly poor outcomes. South Carolina is
one of nine states identified as “key drivers” of the US HIV epidemic, and HIV rates for youth in South Carolina
have risen rapidly in recent years (68% increase in past 15 years). Tailored interventions are urgently needed to
improve outcomes for this population. One promising approach is to reach YLHIV via mobile Health
(mHealth) technology, yet limited efforts have sought to tailor mHealth interventions to the needs of YLHIV in
the Deep South. Thus the scientific objective of this K01 is to identify barriers experienced by YLHIV in South
Carolina and then use findings to develop and pilot-test an mHealth intervention designed to increase
engagement/retention in care and ART adherence. The career development objective of this K01 is to obtain
the mentoring and training needed for a successful, high impact career investigating innovative ways to reduce
HIV disparities among youth in the Southern US. This application is supported by a rigorous, highly productive
research environment at the University of South Carolina and by a distinguished team of mentors. Collectively,
mentors have expertise in psychological, behavioral, and socio-cultural aspects of HIV in the Deep South; the
development of culturally-tailored HIV interventions; the use of mHealth to improve outcomes for YLHIV;
factors related to a successful HIV Care Continuum; and rigorous intervention methodologies to test and
enhance psychosocial and behavioral health interventions. Training experiences will provide expertise in
formative assessment for intervention development; application of mHealth technologies to the HIV Care
Continuum; intervention adaptation and development; theater testing methodology; innovative trial designs
for mHealth interventions; and statistical/analytic skills necessary to assess intervention fidelity, acceptability,
efficacy, and mechanisms of action. Training progression is linked to three specific research aims. In Aim 1, we
will examine barriers to engagement/ retention in care and medication adherence for YLHIV in South Carolina.
We will then use these findings to develop a tailored mHealth intervention to improve Care Continuum
outcomes for YLHIV in the Deep South (Aim 2) by integrating several promising mHealth strategies. In Aim 3,
we will evaluate the feasibility, acceptability, and usability of the mHealth intervention with a six-month pilot
trial with 40 YLHIV in South Carolina. The project is relevant to NIMH priorities as it will bring together key
stakeholders including patients, providers, and researchers to produce a developmentally and culturally
tailored behavioral health intervention that can optimize clinical outcomes. It also aims to use an innovative
service delivery model (i.e., mHealth technology) with a diverse population (i.e., YLHIV in the Deep South) in
order to overcome traditional shortcomings of mental and behavioral healthcare.

Public health relevance
PROJECT NARRATIVE More than one-quarter of all new HIV infections in the United States (US) occur among youth, and youth living with HIV (YLHIV) display poor outcomes at each step of the HIV Care Continuum. These outcomes are particularly poor for YLHIV in the Deep South yet few tailored, innovative approaches are currently available for this key population. The proposed plan for research and career development addresses this critical gap by examining barriers and facilitators to Care Continuum success for YLHIV in the Deep South, and then using these findings to develop and pilot test a mobile Health (mHealth) intervention that aims to increase engagement/retention in care and medication adherence for this population.